Novel Mechanisms of Regenerative Tissue Repair

PROJECT SUMMARY
Postnatal dermal injuries heal with scars, resulting in major health, psychosocial and economic burdens. Our
team has studied the mechanisms of fetal regenerative tissue repair with the ultimate goal to develop anti-
fibrotic therapies. In pursuit of this mission and with previous R01 support, our team has (i) found that IL-10 is
a key regulator of fetal wound repair and promotes scarless healing, (ii) replicated the fetal scarless phenotype
by application of IL-10 on postnatal dermal wounds, (iii) revealed new mechanisms that control extracellular
matrix (ECM) remodeling and neovascularization via high molecular weight hyaluronan (HMW-HA) signaling,
(iv) demonstrated that HMW-HA drives T lymphocyte-mediated IL-10 expression, (v) recently reported a
temporal influx of predominantly CD4+ T lymphocytes in murine skin wounds that correlated with the
proliferative and remodeling phases of wound healing, and (vi) obtained evidence that reconstitution of
immunity by adoptive transfer of functional CD4+ T lymphocytes in severe combined immune deficient mice
significantly reduced inflammation, decreased fibrosis, and healed post-injury dermal wounds with less
scarring. While our collective data strongly suggest a concerted HMW-HA-mediated IL-10-dependent crosstalk
between fibroblast cells and mobilized T lymphocytes in response to injury, little is known about the identity of
IL-10-producing CD4+ T lymphocyte subsets and how they contribute to dermal wound repair outcomes. We
hypothesize that: (a) CD4+ lymphocyte subsets differentially regulate postnatal dermal scarring via IL-10-
dependent signaling and (b) HA and the hyaladherins transduce signals to drive IL-10 production by CD4+
lymphocytes, which reduces scarring risks. To obtain experimental evidence that supports our hypothesis and
provides compelling clues to design effective anti-scar therapies, we propose three specific aims. In aim 1, we
will identify the mechanisms by which IL-10-producing CD4+ T lymphocyte subsets regulate inflammation, ECM
formation and angiogenesis to reduce scar formation in vitro and in vivo. In this and subsequent aims, we will
use unique 10Bit4 mouse models engineered with a triple reporter system - IL-4 (RFP), Il-10 (CD90.1), and
Foxp3 (GFP) - to unambiguously assess the requirement of different T lymphocyte subsets presumed to
transduce anti-scar functions. In aim 2, we will investigate how HA regulates CD4+ lymphocyte production of
IL-10 via CD44 signaling, and determine how HA-stabilizing hyaladherins influence this signaling cascade.
Finally in aim 3, we will determine if HA-mediated endogenous IL-10 production can direct adult fibroblasts
toward a fetal-like regenerative phenotype and if this signaling can influence human scarring phenotypes.
Using our gained knowledge, we will then optimize a translational HMW-HA-based hydrogel treatment system
to promote stable IL-10 production by CD4+ lymphocytes in dermal wounds and test its effects on scarring
outcomes in a preclinical wound healing model. Overall, the proposed aims will reveal new CD4+ lymphocyte
physiology in wound healing and lead to a novel translational treatment paradigm to mitigate dermal scarring.

Public health relevance
PROJECT NARRATIVE The present research addresses a prevalent healthcare problem of dermal scarring that affects patients worldwide after they suffer an injury. Briefly, we aim to identify the cells, molecular mediators, and mechanisms that are directly responsible for directing a wound to heal with or without scar formation. The knowledge obtained from these studies can be harnessed to develop effective therapeutic means to re-direct the way wounds are repaired and thus prevent the debilitating health, psychosocial, and/or economic burdens associated with scarring.